Optimal first line therapies for patients with Cardiovascular-Kidney-Metabolic (CKM) Syndrome.

Optimal first line therapies for patients with Cardiovascular-Kidney-Metabolic (CKM) Syndrome
Approximately 30 million adults have diabetes (DM) in the United States and DM confers a risk for
cardiovascular disease (CVD). Whether CVD is prevented by antidiabetic therapies remains relatively
unknown. Glucagon-like peptide 1 receptor agonists (GLP1RA) and sodium–glucose cotransporter 2 inhibitors
(SGLT2i) demonstrate reduction in CVD and kidney outcomes among those with pre-existing CVD. There is
less known about prevention in those without CVD. Metformin has long been recommended as a first line
treatment for patients and VA guidance is consistent with metformin as a first treatment for DM. The 2022
American Diabetes Association (ADA) guidelines2 differ, however and consider the impact of antidiabetic
medications on prevention of cardiovascular and kidney outcomes. ADA guidance recommends GLP1RA and
SGLT2i as first line for high-risk patients who have no underlying CVD (Stage 2 Cardiovascular Kidney
Metabolic Syndrome (CKM- age 55+ years with hypertension, obesity, dyslipidemia and HbA1c >6.5%). This
represents most older Veterans with new onset DM.2,3
The difference in the optimal treatment in high-risk, drug-naïve patients will not resolve until we have data from
a head-to-head comparison of metformin with newer hypoglycemic medications. We propose to conduct a
national longitudinal study using patient reported, administrative, clinical and laboratory data to quantify the
relative risks/ benefits of first line treatments of DM among Veterans. This proposal will answer the question:
Among patients with Stage 2 CKM and an HbA1c of >6.5% what are the absolute potential
cardiovascular and renal benefits for those who begin treatment with GLP1RA compared to
Metformin? Further is there benefit to use of SGLT2i as a first line treatment?
We will rebuild the National Diabetes cohort of Veterans with an HbA1c of >6.5% and no prior treatment
utilizing national Veterans Health Administration (VHA) data (corporate data warehouse-vital signs; pharmacy,
medical datasets, Medicare/ Medicaid data and vital status files), national death index and additional data on
echocardiograms. Eligible veterans will have new DM and are a new user of an antidiabetic medication (no
use of any DM medications in the prior 180 days). New users of SGLT2i, GLP1RA or Metformin aged >18
years who utilize VHA from 10/1/2000 through 09/30/2023 will be included. We will evaluate the risks and
benefits in those without CVD and conduct a validation analysis in those with CVD. The proposed study follows
this cohort from DM onset and new drug initiation until an outcome or censoring event (leave VHA, change
therapy or death). The comparisons will be: SGLT2 or GLP1RA vs. Metformin. A sample of patients will be
surveyed for validation of drug exposure and covariates.
Aim 1 will test the hypothesis that major adverse cardiovascular events (MACE - AMI/ Stroke/ CV death) in
patients treated with GLP1RA or SGLT2i is lower than Metformin treated patients. Aim 2 will evaluate if CKD
progression is lower in patients treated with GLP1RA or SGLT2 vs. Metformin. Aim 3 will test the hypothesis
that heart failure hospitalization and all-cause mortality is lower for patients treated with GLP1RA or SGLT2 vs.
Metformin. Aim 4 will evaluate 2 mediators (cumulative weight change and systolic blood pressure) as
mediating the impact of GLP1RA on MACE outcomes. Propensity score weighting will be used to achieve
similar groups. Cause-specific hazard ratios will account for baseline covariates and a competing risk of death
or non-persistence. The execution of the proposed research will provide actionable evidence for patients with
DM, impact VHA policy and addresses the research strategic priorities of real-world impact of VA research.
Our team has been extremely productive in the last 11 years and will conduct a rigorous evaluation of the
effectiveness of DM medications leading to impactful outcomes that influence both policy and practice.

Public health relevance
Approximately 30 million adults have diabetes (DM) in the United States and confers a risk for cardiovascular disease (CVD). The VA guidance recommends Metformin as a first line treatment for patients with diabetes as has been the standard for 20 years; however, the American Diabetes Association (ADA) shifted to considering the impact medications have on prevention of cardiovascular and kidney outcomes. ADA guidance now recommends glucagon-like peptide 1 receptor agonists (GLP1RA) and sodium-glucose cotransporter-2 (SGLT2i) inhibitors as the first line treatment. This recommendation is based on limited data. Evidence for the advantages of newer agents versus Metformin is nonexistent as there are no head-to-head comparisons. We propose to conduct a national study using patient reported, administrative, clinical, and laboratory data to compare new agents to metformin treatment among Veterans. This study would be the largest evaluation of antidiabetic medications and addresses a priority of increasing the real-world impact of VA research.